Data Analysis and Modeling Core (DAM)

Data Analysis and Modeling Core – Abstract
The Data Analysis and Modeling (DAM) Core is designed to provide data processing and analysis services to
the four Center Projects, the Career Enhancement Pilot Projects, as well as to the TCORS Consortium, and
the FDA Center for Tobacco Products (CTP). The DAM Core will ensure that there are uniformly high data
collection and analysis standards, as well as consistent measures of tobacco use across research projects.
The DAM Core will also provide the infrastructure for disseminating the resulting tobacco use parameters
(product-specific prevalence, initiation and cessation rates, intensity of use by age, gender, year, and birth
cohort), mortality rates by tobacco use status, and modeling tools and results.